Revealing cell-level gene regulation through integration of single-cell multi-omics measurements

Summary
Advanced single-cell sequencing techniques have enabled us to infer gene regulation at the single-cell level. We
propose to develop computational methods to overcome obstacles for elucidating gene regulation at single-cell
resolution. We ﬁrst present an alignment-based computational framework to integrate single-cell multi-omics
measurements. The alignment-based computational framework can effectively handle the cell type imbalance
problem and is more robust to hyperparameters. Furthermore, we incorporate the integrated single-cell multi-omics
measurements and advanced machine learning algorithms to infer transcriptional regulation, distal regulatory
elements, and post-transcriptional regulation at the single-cell level. We expect to develop computational methods
to better understand gene regulation, which would lay a solid foundation for disease diagnosis, treatment, and
prevention.

Public health relevance
Narrative The proposed research aims to infer gene regulation at the single-cell level. Revealing cell-level gene regulation would not only help to unveil the mystery of the working principle of different living organisms but also provide insights for disease diagnosis, treatment, and prevention.